Enrichment Program

Project Summary
The Enrichment Program provides critical mechanisms to support the overall goals of the Texas Medical
Center Digestive Disease Center (TMC DDC) via the following Specific Aims: 1) To share and disseminate
knowledge gained from the presence of the DDC and in the larger field of digestive diseases. 2) To promote
and increase interaction and collaboration among investigators and clinicians interested in digestive diseases.
3) To foster the scientific and career development of DDC members.
To achieve these aims, The DDC developed and implemented an Enrichment Program that has several
elements : 1) the Research Seminar Series; 2) the Annual DDC Symposium; 3) the Annual DDC
Scientific Retreat; 4) DDC Core Research Workshops; 5) DDC Research Focus Group Workshops; and
6) Career Development Initiative. Institutional and endowed support over the last funding period ($35,000)
sponsored complementary research symposia and lectures within the GI Sections in the three DDC institutions
targeting the research interests of DDC members.
To catalyze member scientific development and interactions, the TMC DDC Research Seminar Series was
initiated in 1998. This weekly series is a vehicle for prominent local, national, and international investigators to
present lectures related to topics within the DDC Research Domains. We started in 2009 an annual scientific
symposium that is organized as a half-day monothematic symposium focusing on topical and cutting-edge
topics, and starting in 2015 became CME accredited. The Directors and/or Co-Directors of the DDC 4
research Cores hold several DDC Core Research Workshops that deal with educational and technical issues
of new technologies or Core activities. We have created several DDC GI Focus Groups including a
Microbiome Analysis Research Group, Liver Biology and Cancer Consortium Research Group and the Junior
Investigators Group, in which junior investigators meet twice monthly to discuss diverse GI research interests
in both basic and clinical sciences. The annual DDC retreat format is designed to disseminate research
findings of our members and includes a poster session, which provides robust interactions among senior
investigators, junior faculty, and trainees. Awards to the best posters are presented during the annual retreat.
The DDC Career Development Initiative sponsors several activities including preparedness for PF awards,
dissemination of grant and career development information to PF awardees, trainees and junior faculty,
lunches with visiting speakers, and Digestive Disease Week (DDW) Rehearsal.
1

Public health relevance
Project Narrative Per instructions in RFA-DK-17-001 we have not included a project narrative in this application. As specified, we have included the narrative in the overall component.